PAIN THRESHOLD IN ADULTS WITH SICKLE CELL DISEASE

This study will examine the effects of rehearsal of cognitive coping strategies (i.e., breathing, relaxation, distraction, pleasant imagery) on pain threshold and tolerance in adults with sickle cell disease.